THE EFFECTS OF CORNEAL CONTACT LENSES ON THE CORNEA

This investigation of short-term as well as long-term effects of contact lens wear on the cornea includes specular microscopy studies of changes in corneal curvature, corneal epithelial morphology, and corneal endothelial cell morphology. Analysis of the data obtained will help us understand the dynamics involved in the interaction between a contact lens and the cornea, the risk to corneal tissues, and how a systemic or local disorder may increase these risks. In addition, we are studying the differences in corneal endothelial status in wearers of soft compared with hard contact lenses. Animal models showing corneal endothelial abnormalities similar to those in long-term contact lens wearers are also being explored in diabetic and galactosemic animal models. Treatment with aldose reductase inhibitors helps prevent these corneal abnormalities.